Shared Resource Core: Quantitative Sciences Core

ABSTRACT | QUANTITATIVE SCIENCES CORE
The Quantitative Sciences Core (QSC) of the Ponce Health Sciences University-Moffitt Cancer Center (PHSU-
MCC) Partnership provides resources and expertise for generating, managing, and analyzing big data. It is the
focal point for expertise in quantitative approaches to address the underrepresentation of Hispanic/Latino (H/L)
populations in “omics” studies and to incorporate ancestry analysis in Partnership research approaches. By
joining PHSU's expertise in genetic ancestry with the MCC bioinformatics team, the QSC combines a unique set
of skills required to address the molecular components of cancer disparities in admixed H/L populations. The
QSC provides expertise in bioinformatics, biostatistics, and informatics, and participates in every phase of the
research life cycle. The QSC supports data provisioning, study design, analysis plans, and power estimates to
demonstrate the feasibility and improve rigor and reproducibility in all Partnership research projects and grant
submissions. In addition, the QSC contributes to the dissemination of high-throughput molecular data by
developing web-based visualization tools. As a central resource for research projects, the QSC also facilitates
collaboration, thereby leveraging the data gathered by the Partnership investigators. The QSC analyzed the first
H/L genomic data generated in collaboration with the Puerto Rico BioBank (PRBB)/Oncology Research
Information Exchange Network (ORIEN) Avatar and implemented the H/L Bioportal (GLOBAL), a web-based
resource. The QSC develops tools for visualizing and interpreting data, pipelines to estimate genetic ancestry,
and has built expertise in genomics bioinformatics at the Hispanic-Serving Institution (HSI), including hiring,
training, and the acquisition of computing and storage infrastructure. The Specific Aims of the QSC will be: 1)
Provide research project support for biostatistics and bioinformatics from study design, endpoint definition,
sample size estimation, power calculation, and data analysis. Regular interactions between lead data scientists
and project members will allow for the continuing development of novel analytic tools to address emerging
questions aligned with the Partnership’s needs. 2) Provide data integration and management services for
Partnership projects and cores. Projects needing tissue/data collection systems will leverage the existing
software infrastructure from PRBB Biospecimen Management System (BMS). The QSC/PRBB Data Concierge
provisions data and linkages from these systems. Other supported services include the H/L Bioportal, Estimated
Cell Line Ancestry (ECLA) tool, and the Partnership Continuous Quality Improvement System for the Planning
& Evaluation Core. 3) Provide quantitative sciences expertise in support of the Partnership. The QSC aims to
develop expertise in statistics at the HSI; characterize publicly available molecular signatures in Partnership
cohorts; develop analytics for PRBB optimization of consent and participant communications; expand the omics
experience for students (collaboration with the Research Education Core) and enhance the use of ancestry in
quantitative studies.